Nanoscience-Inspired Acoustofluidic Assembly Lines for Gene and Cellular Therapies

Project Summary
Stem cell-based gene therapies that leverage gene-editing approaches to address disease-causing mutations
are emerging as viable medical interventions across a variety of pathologies. Current viral-vector-based and
non-viral gene-transfer methods of delivering gene editing machinery, which involve either chemical or energetic
disruption of cell membranes, are used routinely in laboratory settings, but fall short when scaled up for clinically
relevant applications targetting the manufacture of therapeutic cell products. New methods that enable efficient,
rapid, safe, and economical delivery of gene editing packages are needed to support the infrastructures that will
be required to translate these gene therapies broadly for application in patient care. Our solution to this critical
unmet need leverages innovations in gene editing and nanotechnology to render cell membranes transiently
porous, enabling intracellular delivery of biomolecular cargoes. We will design and apply new methods that use
acoustic waves generated within microfluidic systems (i.e., acoustofluidics) to mechanically disrupt cell
membranes, facilitating the rapid and efficient delivery of CRISPR/Cas9 gene-editing components that are
packaged into supramolecular nanocarriers. We use sickle cell disease, one of the most common
hemoglobinopathies worldwide, as an initial clinical target for evaluating the proposed platform as it arises from
a well-defined genetic mutation that can be targetted for site-specific correction in hematopoietic stem cells with
gene editing systems such as CRISPR/Cas9. Successful execution of this research will pave the way for
technologies that enable rapid and sustainable processing of stem cell-based gene therapies at clinically-
applicable doses – effectively establishing scalable, good manufacturing practice-compatible assembly lines for
manufacturing gene modified therapeutic cell products to treat a wide variety of disesases and will streamline
the clinical deployment of future cellular therapies.

Public health relevance
Project Narrative New methods for delivering gene-editing machinery safely, rapidly, efficiently, and economically to disease- relevant cells and tissues are needed to support emerging gene- and stem cell-based therapies. We develop and test new nanotechnology-enabled methods that use acoustic waves generated within microfluidic systems (i.e., acoustofluidics) to disrupt cell membranes mechanically, facilitating the rapid and efficient delivery of gene- editing packages to large populations of cells, and apply this technology for the site-specific correction of the sickle cell disease mutation in hematopoietic stem cells as an initial clinical target for evaluating the proposed platform. Successful execution of this research will inform the rapid and sustainable processing of stem cell- based gene therapies, effectively establishing scalable assembly lines for manufacturing therapeutic cells to treat a wide variety of disesases.